Estrogen Suppression as a Strategy to Enhance Immunotherapy Efficacy in EGFR-Mutated Non-Small Cell Lung Cancer

PROJECT SUMMARY
Non-small cell lung cancer (NSCLC) among never-smokers is on the rise. Mutations in the epidermal growth
factor receptor (EGFR) gene are common and found in >50% of lung tumors from never-smokers. While EGFR-
mutant tumors exhibit robust responses to tyrosine kinase inhibitors, disease progression is unfortunately
inevitable. Many patients with Stage IV NSCLC now experience durable responses and long-term survival
following treatment with checkpoint inhibitors. However, such benefits are rarely seen in patients with EGFR-
mutant disease, where rapid disease progression is frequently observed. The poor responses to checkpoint
inhibitors in EGFR-mutant NSCLCs are likely due to their immunosuppressed “cold” tumor microenvironment
(TME), characterized by low levels of infiltrating CD8+ and CD4+ T cells and high levels of regulatory T cells
(Tregs) and M2 macrophages. An unmet need exists to elucidate the factors that contribute to the
immunosuppressed TME and develop efficacious immunotherapeutic regimens for patients with EGFR-mutant
NSCLC. Emerging data suggest estrogen contributes to an immunosuppressive TME. Data from other cancer
types demonstrate the ability of 17β-estradiol (E2) to regulate several immune cell types, including CD8+ T cells,
Foxp3+ Tregs, macrophages, and neutrophils. Although it is well established that estrogen and its reactive
metabolite 4-hydroxyestrogen (4-OHE) play an important role in lung tumorigenesis, little attention has been
given to their contribution to immunosuppression in the lung TME or the use of estrogen-modulating agents to
attenuate these effects. Preliminary data from our group demonstrate for the first time that administration of an
aromatase inhibitor (AI) to mutEGFRL858R mice significantly increases intra-tumoral CD8+ T cell infiltration and
promotes anti-tumor effects. Furthermore, our new data are the first to demonstrate that: 1) deletion of CYP1B1
(enzyme responsible for 4-OHE production) in mutEGFRL858R mice reduces lung tumor burden by ~50%; 2) 4-
OHE production is significantly enhanced in patients with EGFR-mutant NSCLC as compared to healthy controls;
and 3) 4-OHEs polarize macrophages to the immunosuppressive M2 phenotype, an immune species known to
be enriched in EGFR-mutant tumors. These novel data provide strong rationale for investigating the use of an
AI with anti-PD1 therapy in EGFR-mutant NSCLC. The proposed multidisciplinary research will involve studies
in the mouse models of mutEGFRL858R and delEGFRΔL747–S752 lung adenocarcinoma (Aim 1), complemented by
immune biomarker analyses using archived specimens from patients with EGFR-mutant NSCLC (Aim 2).
Research under both aims will be performed in parallel, to facilitate rapid translation of the resulting data to a
clinical setting and selection of the patient population that will benefit most from an estrogen modulator. Findings
will enhance our understanding of the contribution of estrogen and its metabolites to immunosuppression in the
TME of EGFR-mutant NSCLCs, and inform the design of a novel clinical trial that employs an AI with a checkpoint
inhibitor to improve long-term survival.

Public health relevance
PROJECT NARRATIVE The emergence of immunotherapy has been practice-changing, however patients with EGFR-mutant non-small cell lung cancer (NSCLC) derive little benefit, as their tumors are typically resistant to checkpoint inhibitor drugs. Preliminary data from our group indicate for the first time that using an aromatase inhibitor (AI) to block the production of estrogen and its metabolites in mice with EGFR-mutant NSCLC can significantly increase immune cell infiltration into lung tumors and promote other anti-tumor effects. Suppressing estrogen species with an AI may be an effective strategy to enhance the efficacy of checkpoint inhibitors and improve long-term survival in patients with EGFR-mutant NSCLC.